The role of Foxp1-regulated signaling pathways in brain development and behavior

Abstract: Not applicable for this application.

Public health relevance
Project Narrative: Not applicable for this application.